Characterization of the spatial and temporal response to tau in chronic traumatic encephalopathy

Repetitive head injuries (RHI) from contact sports such as American football, hockey, and soccer, or military
service and intimate partner violence can occur upwards of 1000s of times each year for decades in some cases.
The cumulative damage from these hits have been shown to have profound consequences ranging behavior
and cognitive clinical impairments to overt dementia demonstrating that millions of individuals might be at risk
for long term neurodegeneration after RHI exposure. RHI, specifically the non-concussive injuries, are strongly
linked to the neurodegenerative disease chronic traumatic encephalopathy (CTE). CTE is a tauopathy where
hyperphosphorylated tau (ptau) pathology begins in the frontal cortex at the depths of the cortical sulcus with
foci of neuronal ptau aggregates found around blood vessels (CTE lesion). However, as the disease progresses,
ptau deposition is enhanced and spreads from the frontal cortex to the medial temporal lobe, and ultimately the
whole brain is involved at end stage. Until recently, it was entirely unknown what mechanisms might be involved
linking RHI induced damage to early CTE pathogenesis. However, our initial work has identified
neuroinflammation as a likely driver of disease. To better understand how RHI and ptau affects the brain during
CTE, we will use our unique resource, the Boston University CTE brain bank, the largest CTE brain bank in the
world, to select subjects to profile using cutting edge approaches. We will use frozen tissue from frontal cortex,
hippocampus, and calcarine cortex in each subject that capture early, middle, and late involvement of ptau
progression from individuals diagnosed with RHI exposure and no CTE, low stage CTE, high stage CTE, and
appropriate controls. First, we will perform single nuclei RNA sequencing (snRNAseq) to compare cell population
changes among our groups and across disease progression. In addition, we will use proximal frozen tissue
sections to perform ptau and Aβ ELISAs to measure pathologic protein accumulation in direct contact with the
cells assayed by snRNAseq. We will then perform spatial transcriptomics to investigate how local cell populations
are directly related to pathology using the same snRNAseq tissue. The sections will be stained for ptau and Aβ
pathology prior to sequencing and spatial transcriptomics data will be registered to and correlated with CTE
lesions and Aβ plaques. Finally, we will utilize a cutting-edge tissue culture paradigm to examine mechanistic
connections. We will culture 3D human derived forebrain cortical spheroids (CS) that contain all the major brain
cell types. CS will be treated with isolated ptau aggregates from CTE, and we will examine, tau seeding,
phagocytosis, reactive phenotypes, and genomic profiles to determine the individual neurodegenerative effects.
Overall, these findings will be critical in advancing our understanding of how ptau pathology influences the distinct
neuroimmune phenotypes present in the brain and drives disease. Better characterization of human disease will
lead to better disease models which are critically needed to aid in the discovery of disease modifying therapies
or novel in-life biomarkers. We expect the findings will shed light not only into CTE, but other tauopathies as well.

Public health relevance
Project Narrative Repetitive head injury (RHI) received from sports such as American football is the greatest risk factor for the neurodegenerative tauopathy chronic traumatic encephalopathy (CTE). To address the fundamental questions behind ptau biology and spread, we will utilize postmortem human samples from the Boston University CTE brain bank. Overall, based on our preliminary findings examining neuroinflammatory profiles across pathology, we hypothesize that distinct types of ptau will be mechanistically linked to specific neurodegenerative cell interactions, suggesting novel mechanistic targets to treat CTE.